Leptin Receptor Agonist to Treat Sleep Disordered Breathing

PROJECT SUMMARY/ABSTRACT
Obstructive sleep apnea (OSA) and obesity hypoventilation syndrome (OHS) are the most common types
of sleep disordered breathing (SDB). OSA is highly prevalent in the United States, affecting 20-40% of the
adult population and more than 50% of individuals with obesity. Approximately 20% of individuals with
obesity develop OHS defined as daytime hypercapnia and hypoventilation, attributed to the depressed
control of breathing. There is no effective pharmacotherapy for OSA and OHS. Our overarching goal is
to develop a novel, safe, and effective treatment for sleep disordered breathing (SDB). We have
shown that an adipocyte-produced hormone, leptin, which suppresses appetite and increases
metabolic rate, stimulates breathing during sleep. Individuals with obesity have high circulating leptin
levels, but they are resistant to its beneficial metabolic and respiratory effects. Our laboratory has
extensively studies sleep and breathing in mice. We have shown that mice with diet-induced obesity
(DIO) develop OHS and OSA, despite high plasma leptin level. Limited permeability of the blood-brain
barrier (BBB) for leptin is a key mechanism of leptin resistance. Leptin receptor (LEPRb) agonists
engineered to penetrate the BBB are promising therapeutic candidates for SDB treatment. Dr. Laszlo
Otvos has developed E1/Aca, a LEPRb agonist, which has been shown to be BBB permeable and
superior to leptin for weight loss and metabolic dysfunction in mice and rats. We established a
collaboration with Arrevus, which holds a license to E1/Aca, and developed our research plan
to characterize E1/Aca’s potential therapeutic benefit in SDB. We will build upon significant
preliminary data to demonstrate a proof-of-concept for the use of the leptin receptor agonist,
E1/Aca, to treat SDB. Using polysomnography in leptin-resistant diet-induced obese (DIO)
mice, two specific aims will be completed to evaluate the acute (SA1) and chronic (SA2)
activity of E1/Aca in SDB. Specific Aim 1 will characterize the potency of a single
subcutaneous injection of E1/Aca on SDB, compared to leptin. We will evaluate the effect of
escalating doses of E1/Aca on (A) OSA severity (the oxygen desaturation index, the apnea-
hypopnea index, and minute ventilation during sleep) compared to a fixed dose of leptin; (B)
Obesity hypoventilation (arterial CO2 and the hypercapnic ventilatory response awake) compared to
a fixed dose of leptin. Specific Aim 2 will characterize the chronic effects of E1/Aca on SDB
compared to leptin. We will evaluate the potency and safety of the optimal dose of E1/Aca identified
in Aim 1 in DIO mice over a two-week period on (A) SDB severity; (B) Safety by assessing effects of
E1/Aca on CNS, cardiovascular, pulmonary, endocrine, and liver toxicity.

Public health relevance
PROJECT NARRATIVE Sleep disordered breathing (SDB) includes obstructive sleep apnea (OSA) and obesity hypoventilation syndrome (OHS). Obstructive sleep apnea is a common complication of obesity with devastating cardiovascular complication. There is no available drug treatment for OSA and OHS. We have previously shown that the hormone leptin stimulates breathing and treats SDB, acting in the brain. Obese individuals are resistant to leptin due to poor penetration of this hormone to the brain. We have developed a drug, E1/Aca, which readily penetrates the brain and we will examine the safety and activity of this drug for OSA and OHS treatment in our obese mouse model of SDB.